PepSAVI-MS for discovery of novel botanical antimicrobial peptides

ABSTRACT
The continued evolution of antimicrobial resistance emphasizes the dire need for discovery of antibiotic
therapeutics with novel mechanisms of action. Technological advances in genome sequencing, drug library
creation, and structural informatics have not advanced infectious disease treatments sufficiently. While natural
products have long served as inspiration for novel therapeutic scaffolds, we posit peptide-derived entities offer
great potential to address current needs due to their unique mechanisms of action, penetration and selectively.
Herein, we describe our PepSAVI-MS pipeline to discover and characterize peptides with antimicrobial activity
through implementation of a hybrid bioassay-guided/peptidomics platform. We directly identify botanical
peptides contributing to bioactivity profiles using robust microbial bioassays optimized for peptide screening
and using a mass spectrometry-based peptidomics approach coupled to statistical modeling and informatics to
identify and further characterize these peptides at the molecular level. These potential lead compounds are
then tested against an extensive panel of clinical ESKAPE pathogens, as well as for favorable drug
characteristics and determination of mechanism-of-action. Our platform enables robust mining of plants and
other natural sources for peptidyl species with unique or broad-spectrum anti-infective properties and has the
potential to lead to the discovery of novel chemistries at the forefront of modern drug discovery.

Public health relevance
PROJECT NARRATIVE Plant diversity has barely been tapped through either random or knowledge-based bioactivity screening approaches, and certainly not in the context of or in a manner amenable to the identification of bioactive peptides. This proposal aims to discover, characterize, and validate as potential drug lead compounds botanical antimicrobial peptides active against the ESKAPE pathogens using the PepSAVI-MS pipeline developed in our laboratory that incorporates mass spectrometry-based peptidomics and biological activity testing through statistical modeling and informatics to identify active compounds. Identifying new bioactive peptide scaffolds/lead compounds will facilitate development of treatments for drug-resistant bacterial infections in which limited or no antibiotic treatment options remain.